Unobtrusive remote monitoring to identify and track meaningful change in daily function in community dwelling older adults at risk for Alzheimer's disease

Resubmission 1 R01 AG058687-01 PI:
Adriana Seelye, Ph.D.
Project Summary. Alzheimer's disease (AD) is a growing public health concern that has a profound negative
impact on individuals living with the disease and their families, the healthcare system, and the economy. Early
identification and accurate assessment of mild cognitive and functional deterioration in older adults at risk for
AD will be critical in order to intervene at the earliest stages of the disease and to reduce the cost and
consequences of functional declines. Project Objectives. The overall goal of this research is to use
unobtrusive in-home sensor technologies in the home environment to objectively assess high-level IADL
functioning in a new way that will more effectively identify the earliest subtle declines in functioning that slowly
emerge and ultimately threaten independence. The specific aims for this research are: Aim 1 will establish the
most robust remotely monitored IADL variables and combinations of variables to discriminate between MCI
and intact cognition based on sensitivity, specificity, accuracy and overall ROC AUC using cross-sectional
analyses. Aim 2 will determine the discriminatory ability of the new remotely monitored IADL variables
compared to available IADL questionnaires to differentiate those with MCI relative to those with intact cognition
based on sensitivity, specificity, accuracy and overall ROC AUC in cross-sectional analyses. Aim 3 will identify
and characterize the longitudinal trajectories (slopes) of remotely monitored IADL functioning over time
between those with intact cognition and those with MCI using generalized linear mixed effects models, with
person-specific IADL distributions and their changes as outcomes. Project Methods. The proposed project
will apply innovative computing and ambient sensing technologies directly in participants' home and
community environments to objectively assess IADL performance and variability among older adults with and
without MCI in multiple clinically relevant functional domains for up to 4 years. Study involvement will also
include annual neuropsychological and clinical testing. Machine learning computational approaches will be
used to examine a large number of sensor-based IADL candidate variables generated through this study to
determine the relative importance of these variables for discriminating between MCI and intact cognition
groups, cross-sectionally and longitudinally. Project Impact. The approaches used in this study will allow
researchers, physicians, and caregivers to proactively identify and monitor increasing risks for deteriorating
cognitive function (progressing from normal aging to MCI and from MCI to AD) in a way that is not currently
possible, transforming AD prevention trials and significantly reducing the cost and consequences of functional
decline in our aging population.

Public health relevance
Project Narrative Alzheimer's disease (AD) is a growing public health concern that has a profound negative impact on individuals living with the disease, their families, the healthcare system, and the economy. Early identification and accurate assessment of mild cognitive and functional deterioration in older adults with who are at risk for AD will be critical in order to intervene at the earliest stages of the disease and the reduce the cost and consequences of functional declines. The overall goal of this research is to use unobtrusive in-home sensor technologies in the home environment to assess day-to-day functioning in a new way which will more effectively identify the subtle declines in functioning that slowly emerge and ultimately threaten independence.